Central IRB Services for NIAID Coronavirus COVID-19 OWS ACTIV-3 Clinical Trial

The purpose of this funding is to provide the Central Institutional Review Board (IRB) services for the Coronavirus COVID-19 ACTIV-3 trial.